Mechanisms of Il-2-mediated immune tolerance

PROJECT SUMMARY
Foxp3+ regulatory T cells (TR) are essential for establishing and maintaining immune tolerance, and manipulating
TR activity is an attractive new therapeutic strategy for treating autoimmune and inflammatory diseases. The
development, homeostasis and function of TR depends on the cytokine IL-2, and TR constitutively express the
high affinity IL-2 receptor which allows them to compete for limiting IL-2 produced by activated CD4+ T cells. As
a strategy for increasing TR abundance and function to treat autoimmune disease, we have developed a novel
IL-2 ‘mutein’ that is highly TR selective, potently expands TR in vivo, and arrests ongoing autoimmunity and
induces durable disease protection in NOD mice. Interestingly, we have shown that in both mice and humans,
IL-2 mutien treatment is associated with pronounced expansion of a subset of highly activated TR characterized
by expression of activation markers associated with T cell receptor stimulation. Furthermore, expanded TR
express high levels of the immunosuppressive molecule CTLA4, and IL-2 mutein treatment inhibits the activation
of dendritic cells (DCs) and their surface expression of the key co-stimulatory ligands CD80 and CD86 that are
required for full effector T cell activation. Based on these results, we hypothesize that IL-2 mutein treatment
promotes TR/DC interaction, and that this results in synergistic IL-2 and TCR signaling that drives the proliferation
and expansion of highly activated TR that inhibit DC function and prevent the activation, differentiation and
function of autoreactive T cells. In this proposal we use a number of innovative methods to test this hypothesis,
and these experiments will provide a comprehensive mechanistic understanding of how IL-2 muteins function to
promote TR expansion and induction of immune tolerance. This has important implications for the translation of
IL-2 muteins into therapeutic use, and will provide important new insights in the basic biology of IL-2-mediated
control of TR homeostasis and function.

Public health relevance
PROJECT NARRATIVE We have developed a novel IL-2 ‘mutein’ that is highly selective for Foxp3+ regulatory T cells (TR), potently expands TR in vivo, and arrests ongoing autoimmunity and induces durable disease protection in pre-clinical models of autoimmunity. Mechanistically, we hypothesize that IL-2 mutein treatment promotes functional interactions between TR and antigen-presenting dendritic cells (DCs), and that this results in synergistic IL-2 and TCR signaling that drives the proliferation and expansion of highly activated TR that inhibit DC function and prevent the activation, differentiation and function of autoreactive T cells. In this proposal, we will test each aspect of this hypothesis using innovative murine models to provide a comprehensive mechanistic understanding of how IL-2 muteins function to promote TR expansion and induction of immune tolerance.